GuidedOR: A Real-Time Medication Safety Software Platform for the Operating Room

GuidedOR: A Real-Time Medication Safety Software Platform for the Operating Room
Medication administration in the operating room (OR) bypasses many of the standard safety checks that exist
throughout the rest of the hospital. For example, due to the fast-paced clinical environment, high acuity and
rapidly changing patient condition in the OR, medications are typically administered without prospective
medication orders, double-checks by second providers, or electronic clinical decision support to warn of
medication errors. As a result, about 4-10% of medication administrations, or almost every second operation,
involves a medication error. About half of these errors lead to observed patient harm, and the remainder have
the potential for patient harm. The cost of the harm due to errors is $5.3 billion annually in the US alone, and
more than two-thirds of the harm is serious or life-threatening. GuidedOR is a novel OR clinical decision
support software platform that is integrated with the electronic health record (EHR) and uses real-time data to
display patient-specific information and alerts on the OR computer monitor to prevent errors. Briefly, the
barcode on a medication syringe label is scanned immediately prior to medication administration. The scan
triggers GuidedOR to display a dosing window containing the dose, time administered, route, and/or alert(s)
when necessary to prevent a medication error prior to the medication being administered. The clinician simply
confirms the dose or enters an alternative dose if needed. After the medication passes through GuidedOR’s
algorithms, the medication data are sent to the EHR in real-time for automated documentation. In an RCT, the
GuidedOR prototype substantially outperformed standard medication use workflows by improving clinician
workflow efficiency (clinicians saved > 20% of their time) and quality of care metrics including tighter blood
pressure control, more accurate medication dosing and better pain management. In addition, on first-time use
of GuidedOR, clinicians rated its usability double that of existing EHRs. Through iterative feedback sessions
with key customer and company stakeholders, we have identified the following additional critical functionality
that is required to achieve commercialization and widespread adoption of GuidedOR: support for local
anesthetic systemic toxicity, glucose management and perioperative antibiotic management. In Phase I of this
SBIR Fast-Track project, we will identify user requirements and functional requirements for this critical new
functionality, and deploy the new algorithms to Epic’s testing tool at Mass General Brigham. In Phase II, we will
iteratively identify usability challenges and implement solutions. We will then perform end-to-end testing of
GuidedOR, including building a noninteractive “silent mode” that we will use to evaluate algorithm behavior in
live surgical cases. With the addition of the proposed critical functionality, GuidedOR will transform the field of
medication safety, making surgery and anesthesia safer for patients, more efficient for clinicians, and more
cost-effective for hospitals and payors.

Public health relevance
Project Narrative Medication administration in the operating room today presents particular patient safety challenges because it bypasses standard safety checks that exist throughout the rest of the hospital. As a result, 4-10% of medication administrations (or almost every second operation) involve a medication error, about half of these lead to observed patient harm costing the US healthcare system $5.3 billion annually, and more than two-thirds of the harm is classified as serious or life-threatening. GuidedOR clinical decision support software platform is fully-integrated with clinical systems and workflows and uses real-time data to display patient-specific information and alerts to target 95% of intraoperative medication errors, making surgery and anesthesia safer for patients, more efficient for clinicians, and more cost-effective for hospitals and payors.